Yoga, Aerobic and Stretching Exercise Effects on Neurocognitive Performance: A Randomized Controlled Trial

Abstract
Yoga, a physical activity based mind-body therapy has become increasingly popular as a preventive and
therapeutic practice, making it one of the therapies with the most rapid increase in prevalence. Practice of yoga
combines physical activity, modulated breathing and meditative exercises that combine to provide the
practitioner a holistic mind-body experience. The effectiveness of yoga has been examined for a number of
health outcomes, including stress, anxiety, depression, management of chronic conditions such as lower back
pain and type 2 diabetes. Fewer studies have examined the effects of yoga practice on brain health and
cognitive function. Age related cognitive decline is well documented. With the increasing population of older
adults in the US, there is a need to not only test popular forms of exercise such as yoga, but also compare
their efficacy with modalities such as aerobic exercise that have proven neurocognitive benefits. This research
is timely in that yoga is a gentle and modifiable form of exercise that can be easily adapted for practice by older
adults who may exhibit comorbidities or chronic health conditions that keep them from walking or performing
other forms of aerobic exercise. To our knowledge, this is the first randomized control trial examining
and comparing the effects of yoga and aerobic exercise training on behavioral and neurobiological
correlates of cognitive function.
We propose to conduct a 6-month randomized controlled exercise trial among older adults to compare the
efficacy of yoga with aerobic exercise on cognitive function, brain structure and function, cardiorespiratory
fitness, functional fitness, and inflammatory and molecular markers. Using a single-blind, three arm
randomized control trail, 168 older adults ages 55-79 will be assigned to either: a Hatha yoga group, an
aerobic exercise group or an active stretching and strengthening control group. The groups will engage in
hour-long group exercise sessions 3x/week. A comprehensive neurocognitive test battery, brain imaging,
cardiovascular fitness test, and a blood draw will take place at baseline; end of the 6-month intervention, and at
12-month follow-up.
The proposed pilot RCT will examine the relationship between yoga training and improved cognitive
functioning as well as identify neurobiological correlates as potential mechanisms of action through
which yoga training exerts its effect on cognitive function.
The investigative team is interdisciplinary, highly productive and has a history of collaboration in conducting
exercise interventions examining neurocognitive outcomes in older adults.

Public health relevance
Narrative The proposed trial has significant public health relevance as it aims to determine the effectiveness of an increasingly popular mind-body therapy of yoga, its effects on cognitive functioning and its potential to remediate and improve cognitive health among older adult populations. Given the modifiable nature of yoga and its suitability for older adults and individuals with different functional abilities, it seems to be a promising cost-effective and feasible mode of activity to promote cognitive, psychological as well as physical well-being in older adults.